Investigating the role of type 1 interferon signaling on vaccine stability within lymphatic endothelial cells

PROJECT SUMMARY/ABSTRACT:
Lymphatic endothelial cells (LECs) act as the first point of contact for antigen and immune cells entering
the lymph node (LN) via lymphatic vessels. LECs comprise the subcapsular sinus as well as medullary/cortical
structures of the LN. These cells, however, play more than a structural role. Antigen acquired by LECs following
protein subunit immunization or viral infection is retained six weeks or more and is actively transferred to dendritic
cells for presentation to memory CD8+ T cells. This process of antigen archiving and exchange enhances CD8+
T cell function and local protective immunity. While this process of “antigen archiving” is well supported, little is
known regarding the molecular pathways activated at the time of vaccination that facilitate archiving in LECs.
Furthermore, the capacity of these cells to retain material from mRNA vaccines has not been evaluated
A core requirement for antigen archiving is the presence of an innate stimulus. Adjuvants that induce
antigen archiving rely in part or entirely on stimulation of virus-sensing toll-like receptors (TLRs) which lead to
rapid type 1 interferon production in the LN. Furthermore, the degree of antigen persistence is dose-dependent
on quantity of TLR agonist. Based on our preliminary findings, we hypothesize that protein and RNA delivered
by protein subunit or mRNA vaccination persists for longer periods in LECs that have been stimulated by type 1
IFN. Our aims are as follows: (1) Determine if type 1 IFN response in LECs promotes antigen archiving and
enhances protective immunity and (2) Determine how type 1 IFN signaling within LECs regulates vaccine
RNA stability and downstream protective immunity. These aims are significant because they will lead to an
understanding of stimuli that can prolong mRNA vaccine and protein subunit vaccine half-life in the LN and
enhance T cell mediated immunity, which is relevant to vaccine adjuvant design.

Public health relevance
PROJECT NARRATIVE Vaccine antigens persist within lymphatic endothelial cells in the mammalian lymph node with proven immunologic benefit. mRNA vaccines delivered by lipid nanoparticle are also known to persist in the lymph node. In this proposal, we aim to determine the role of type 1 interferon signaling in LECs as it pertains to vaccine mRNA and vaccine protein persistence to better understand the mechanisms of vaccine generated immune memory.